Core A Fshd Bioresources Core

CORE B: ADMINISTRATIVE CORE The overall goal of the Administrative Core is to provide administrative, fiscal and scientific management of this POl Program Project Grant. Key components of this Core will be to provide overall fiscal and administrative coordination. Additional objectives of this Core include organizing scientific interactions communications, and to coordinate interaction with NINDS.

Public health relevance
The multi-investigator components of a Program Project Grant require a central Adminisrative Core to assure standard adherence to NIH fiscal and research policies and to coordinate the communications among the groups.